Ethics of HIV-related research involving underage key populations in sub-Saharan Africa

Many youth who sell sex and adolescent men who have sex with men in sub-Saharan Africa are at high risk for
HIV and other adverse health outcomes. However, these youth are often excluded from studies conducted with
key populations in the region due to legal and ethical challenges. For example, the requirement to obtain
parental consent for the participation of minors in research is often not safe or practical for youth whose sexual
behaviors are stigmatized. This exclusion from research hinders the development and testing of interventions
tailored for underage key populations. This project's long-term objective is to identify legal and ethical barriers
to conducting HIV research with underage key populations in sub-Saharan Africa in order to inform strategies
for overcoming these barriers to implement such research where it is feasible and warranted. The specific aims
of this study are: (1) To examine the relationship between legal restrictions related to the participation of
minors under the age of 18 in research and the implementation of studies including underage key populations
(female sex workers and men who have sex with men) in 48 countries in sub-Saharan Africa. The content of
each country's ethical and regulatory guidance on research with minors will be analyzed, and a systematic
review of the literature on key populations in Africa will be conducted to determine where and what types of
research (e.g., observational or therapeutic) have been conducted with underage key populations. (2) To
assess through surveys the knowledge, attitudes and experiences of research ethics committee members and
institutional review board members (n=419) in sub-Saharan Africa regarding the review of studies that include
underage key populations as participants. We will analyze the country-level, committee-level, and individual-
level characteristics associated with willingness to consider approving research with underage key populations.
(3) To identify perceived obstacles to conducting research with underage key populations in Africa through
surveys of two groups of researchers who have conducted studies with key populations in Africa: those who
have a) included underage participants (n=50) and b) excluded underage participants (n=125). Deliberative
focus group discussions will also be conducted with researchers and research ethics committee members.
Findings will be disseminated to researchers, ethics committee members, and organizations representing
youth and key populations in Africa.

Public health relevance
Despite their high risk for HIV acquisition, key populations under the age of 18--including youth who sell sex and adolescent men who have sex with men--are often excluded from research that can potentially improve their health in sub-Saharan Africa. Increased understanding of ethical challenges and solutions in HIV research with underage key populations in African settings can reduce barriers to the responsible conduct of such research. This study will involve a systematic review of where and how underage key populations have been included in HIV research in Africa, surveillance of African countries' policies on parental consent for minors' participation in research, and surveys and focus groups of research ethics committee members in Africa and HIV researchers who have conducted studies with key populations in Africa that included or excluded minors.